REGIONAL CEREBRAL METABOLIC ACTIVITY DURING REM SLEEP

This study using PET technology is designed to determine if the measurement of regional cerebral metabolic rate of glucose during REM sleep (rCMRgluREM) will provide a more sensitive measure of limbic dysfunction in bipolar dis- order and depressed patients than will a waking PET study.